Characterization of metal cofactors involved in GDGT-MAS Csp3-Csp3 bond formation

Project Summary
Enzyme-catalyzed Csp3-Csp3 bond formation initiated from two inert carbons has been elusive in
biological systems. Until recently, no known enzyme had been described to exhibit such activity; however, it was
proposed that if such activity did exist, it would need to be facilitated through two sequential radical initiations, of
which the initial radical would need to be stabilized until prior is formed. Members of the radical S-
adenosylmethionine (RS) enzyme superfamily are characterized by an open coordination site [4Fe-4S] cluster,
which facilitates reductive cleavage of S-adenosylmethionine (SAM) to form methionine and a 5’-deoxyadenosyl
radical (5’-dA•). This highly reactive 5’-dA• abstracts hydrogen (H•) from inactivated carbons on a wide range of
substrates, affording diverse biological reactions. Recently, our lab identified glycerol dibiphytanyl glycerol
tetraether (GDGT) - macrocyclic archaeol synthase (MAS) from Methanocaldococcus jannaschii, an RS that
facilitates the Csp3-Csp3 bond formation from two inert carbons. Natively, GDGT-MAS catalyzes the formation of
a membrane-spanning macrocyclic lipid, GDGT, and macrocyclic archaeol (mA), which, when present, affords
the host high thermal, pH, and osmotic stability. Such features make macrocyclic tetraethers attractive drug
delivery nanocontainer components. However, the proposed mechanism of Csp3-Csp3 bond formation only
describes the role of two of the four total metal cofactors in the enzyme: the RS domain [4Fe-4S] ([4Fe-4S]RS)
and the C-terminal [4Fe-4S] cluster ([4Fe-4S]C). In our previously published work, we provided evidence that
post-radical initiation of the first terminal sp3 carbon, the radicalized phytanyl chain forms a C-S bond with the
sulfur of the [4Fe-4S]C cluster. This bond formation is predicted to protect the radical intermediate while
sequential radical initiations occur. However, additional evidence is needed to confirm the existence of the C-S
intermediate. Additionally, it remains unknown how the remaining metal cofactors, the rubredoxin-like Fe ion and
N-terminal [4Fe-4S] ([4Fe-4S]N), might influence this novel bond formation.
This proposed work aims to elucidate the role of the metal cofactors in GDGT-MAS, the first documented
enzyme to facilitate the formation of Csp3-Csp3 bonds from two completely inert carbons. Preliminary data shows
that the Booker Lab has found conditions that generate excess C-S bond intermediate while successfully
obtaining soluble metal cofactor knock-outs. This proposal outlines the spectroscopic and electrochemical
characterization of GDGT-MAS and its variants (Aim 1 and 2). Furthermore, in silico experiments designed to
characterize the role protein and lipid dynamics play in the metal cofactor-mediated Csp3-Csp3 formation are
outlined (Aim 3). These include utilizing molecular simulations to characterize lipid translocation into the active
site and identifying environmental factors that may facilitate such.

Public health relevance
Project Narrative The enzyme-mediated Csp3-Csp3 bond formation between two completely inert carbons was unprecedented until the crystallization and subsequent characterization of Radical S-Adenosyl methionine (RS) enzyme GDGT–macrocyclic archaeol synthase (MAS). The ability to selectively form a Csp3-Csp3 bond between inert carbons is highly sought after in organic chemistry; however, little is known about GDGT-MAS’s associated metal cofactors (three [Fe4S4] clusters and rubredoxin-like Fe) in facilitating this novel biological reaction. This project aims to investigate the role of the rubredoxin Fe and N-terminal domains [Fe4S4] in GDGT-MAS.